Behavioral and neural characteristics of adaptive speech motor control

PROJECT SUMMARY/ABSTRACT
Sensorimotor learning plays a critical role in the acquisition and refining of all skilled movements, including
speech production. From early babbling to fully mature speech articulation, auditory-motor learning reflects
central nervous system processes involved in acquiring and updating neural representations of the intricate
motor-to-auditory transformations from motor commands to vocal tract movements and speech sound output.
Auditory-motor learning is also believed to play an important role in the etiology of developmental speech
disorders such as stuttering and childhood apraxia of speech. Over the past two decades, the PI’s laboratory
has made important contributions to the field’s understanding of the key mechanisms underlying such speech
auditory-motor learning in children and adults. We now propose a novel series of experiments, combining
behavioral learning paradigms with a highly innovative neurophysiological approach that allows us to both
modulate and record subcortical neural activity. Specifically, we aim to investigate (a) how speech auditory-
motor learning can be enhanced and how decay of learning can be minimized, (b) whether feedforward
auditory-motor learning also drives updates in feedback control policies, (c) which theoretical insights can be
gained from the subset of individuals who are “followers” and paradoxically use a control strategy that leads to
increasing auditory error rather than adaptation, and (d) whether, at the neural level, cerebellar and basal
ganglia circuits play a distinct role in speech auditory-motor learning versus other forms of speech motor
learning. The inclusion of experiments on the neural bases of auditory-motor learning leverages state-of-the-art
sensing technology available in very recent Deep Brain Stimulation (DBS) implants with electrodes in either
thalamic ventral intermediate nucleus (receiving cerebellar output) or subthalamic nucleus (basal ganglia).
Overall, these integrated experiments will elucidate the processes, mechanisms, and neural substrates
involved in speech auditory-motor learning. They will also reveal the developmental progression of auditory-
motor learning, differences in auditory-motor learning between children and adults, as well as similarities and
differences in speech sensorimotor learning vs. limb sensorimotor learning. Furthermore, given that auditory-
motor adaptation paradigms cause speakers to implicitly alter their speech output quickly and without effort,
this line of work supports the future long-term goal of developing novel, computer-assisted clinical procedures
that induce adaptive changes in speech behavior by systematically altering the speaker’s auditory feedback.
Thus, the work is directly relevant to public health as the generated knowledge will deepen our understanding
of typical speech development, the maintenance of speech articulation skills throughout the lifespan, and
fundamental sensorimotor mechanisms underlying developmental speech disorders while simultaneously
paving the way for highly innovative clinical techniques for the treatment of a variety of speech disorders.

Public health relevance
PROJECT NARRATIVE This series of studies will contribute to a better understanding of how the brain learns the articulatory movements involved in speech production and how it remains able to adjust those movements based on hearing our own speech sounds. The knowledge gained from this work will make it possible to improve theoretical models of the processes involved in speech sensorimotor learning and to pursue new directions of research on the etiology of developmental speech disorders in which sensorimotor learning may be impaired. In addition, the research findings will suggest innovative techniques for treating speech disorders in children and adults.